Neuroimaging genetics to study social cognitive deficits in ASD and schizophrenia

Recent advances in epidemiologic, brain-imaging, and genomic studies suggest that autism spectrum disorder (ASD) and schizophrenia (SCZ), two of the most heritable and pervasive neurodevelopmental disorders, may share some common etiologic mechanisms. While the two disorders are markedly distinct in terms of developmental trajectories and clinical presentations, it has long been recognized that there is considerable overlap of social cognitive deficits. It is thus a highly plausible yet unanswered question whether this overlap in social cognitive deficits reflects common etiological mechanisms, or represents superficial similarities due to comorbidity or misdiagnosis between these two illnesses. The applicant, Dr. Phil H. Lee proposes to address this research question through integrative neuroimaging genetic studies of ASD and SCZ, starting from genes to neural circuits, and ultimately to behavioral measures of social cognition. Owing to years’ of efforts from worldwide collaborators, Dr. Lee now has access to large-scale genotype data (for genome-wide SNPs, N=32,921; for whole-exome-sequencing data, N=7,000) and an independent neuroimaging cohort of ASD, SCZ cases and healthy controls for whom a rich set of brain imaging and behavioral measures are available (N=3,752). Using these exceptionally powerful resources, she will investigate predictive relationships between common ASD and SCZ genetic risk burden and brain imaging/behavioral indexes of social cognitive functioning. The successful completion of this study will thus: (1) clarify how genetic variations at multiple levels (i.e., common and rare variants) influence brain structure/function and the development of core social deficits transcending traditional nosologic boundaries; (2) develop novel analytic strategies that are highly innovative and of general applicability to the studies of complex traits; and (3) lay the foundation for the development of biology-based prevention and remediation strategies for this core brain deficit. Dr. Lee’s career goal is to study the etiologic pathways of severe neurodevelopmental disorders, such as autism and schizophrenia, using an integrative analysis of genetic and neuroimaging data. This proposal builds on her postdoctoral training in psychiatric statistical genetics, centered on genome-wide association studies of a variety of neuropsychiatric disorders. While working towards accomplishing the proposed study, Dr. Lee will receive in-depth research training from world’s leading experts in computational genetics, clinical psychiatry, and cognitive neuroscience. This K99 Award will thus provide her with crucial and timely support to develop into an independent translational geneticist, who can effectively design and conduct neuroimaging genetic studies, ensure the validity, reliability and clinical applicability of the research work, and most importantly, is capable of translating the research findings into great public health benefits through the development of evidence-based prevention, diagnosis, and treatment strategies.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project aims to elucidate the neural/genetic basis of social cognitive deficits commonly featured in autism spectrum disorder (ASD) and schizophrenia (SCZ). Our two-stage analysis consists of: (1) identification of susceptibility genes and biological pathways contributing risk to both ASD and SCZ; and (2) integrative statistical analysis of genetic and neural correlates of social cognition to infer their etiologic relationship. The successful completion of this project will lay the foundation for the development of effective prevention and remediation strategies for social cognitive deficits, which are key determinants of functional disability in ASD and SCZ due to a lack of effective treatment.